Negative regulatory mechanism of mechanically activated PIEZO2 channels by TMEM120A/TACAN

Abstract:
Mechanically activated PIEZO2 channels are highly expressed in dorsal root ganglion (DRG) neurons mediating
light touch sensing and proprioception. While PIEZO2 is crucial for these sensory functions, little is known about
auxiliary proteins regulating its mechanosensitivity. We have identified TMEM120A (TACAN) as a robust and
specific negative regulator of PIEZO2 channels. TMEM120A was initially proposed to be a novel ion channel in
DRG neurons contributing to mechanosensitivity. We were unable to reproduce mechanically activated currents
from TMEM120A along with several other groups. TMEM120A’s structure does not resemble any known ion
channel, but it does have structural homology to Elongation of Very Long Chain Fatty Acids 7 (ELOVL7). Directly
supplementing cells with dietary fatty acids or activating lipid modifying enzymes can inhibit or prolong the
activation of mechanically activated ion channels. In cells co-expressing PIEZO2 and TMEM120A, we observed
a significant reduction in PIEZO2 mediated peak current amplitudes, but we did not observe any changes to
PIEZO1 or TREK-1 in TMEM120A’s presence. Using liquid chromatography tandem mass spectrometry (LC-
MS/MS), we have identified a robust upregulation of lipids in TMEM120A expressing cells such as
lysophosphatidic acid, and phosphatidic acid. We also began determining whether TMEM120A’s lipid modifying
function is necessary for PIEZO2 inhibition. A single point mutation to a hypothesized catalytic residue within
TMEM120A resulted in significantly less PIEZO2 inhibition compared to wildtype. Supplementing cells with
dioctanoyl-phosphatidic acid (a lipid upregulated by TMEM120A) robustly inhibited PIEZO2 channel activity but
did not affect PIEZO1 activity. Using a light activated phospholipase D (Opto-PLD) that generates phosphatidic
acid from existing lipids in the membrane (predominantly from phosphatidylcholine), we observed significant
PIEZO2 inhibition but not PIEZO1. Our preliminary data indicate that TMEM120A specifically inhibits PIEZO2
channels by upregulating phosphatidic acid. Finally, we show preliminary data indicating that extracellular
application of carbacyclic phosphatidic acid (a cyclic analog of phosphatidic acid) reduces PIEZO2 current
amplitudes. Carbacyclic phosphatidic acid’s head group forms a ring structure with the glycerol backbone
reducing the likelihood of it being metabolized into lysophosphatidic acid or phosphatidic acid. Additionally,
administration of carbacylcic phosphatidic acid has been reported to alleviate mechanical pain in animal models.
The mechanism for this analgesic function remains an intriguing and open question. We propose further
investigation necessary to better assess how TMEM120A’s putative lipid modifying function specifically inhibits
PIEZO2 channels. We also propose further inquiry to determine whether carbacyclic phosphatidic acid
administration is sufficient to inhibit PIEZO2 channels in DRG neurons and reduce PIEZO2 mediated
mechanosensation (light touch and inflammatory mechanical allodynia). Generating additional knowledge of
this robust regulatory event will have a substantial impact in our understanding of mechanosensation.

Public health relevance
Project Narrative: PIEZO2 channels are necessary for sensing inflammation induced mechanical pain affecting millions of Americans each year causing substantial economic and emotional burdens. Identifying robust and selective inhibitory mechanisms of PIEZO2 contributes to an emerging field of mechanosensation which has recently been recognized by the Nobel Prize. We propose an intensive inquiry into the robust, selective inhibition of PIEZO2 channels by a possible lipid modifying enzyme (TMEM120A) contributing to a growing body of evidence implicating lipids as key modulators of mechanosensation.